Development of a robotic ankle assist device to improve mobility in individuals with movement disorders.

PROJECT SUMMARY/ABSTRACT
A child’s ability to engage in physical activity is essential to their health, independence, and general well-being.
Many of the 500k children in the United States with cerebral palsy (CP), the most common cause of pediatric
physical disability, have difficulty walking and participating in physical activity. This reduced physical activity in
CP is a primary contributor to the greater incidence of metabolic dysfunction, cardiovascular disease,
osteoporosis, pain, and diminished psycho-social quality of life. Unfortunately, half of all ambulatory children with
CP lose the ability to walk independently in adulthood, indicating that the current approaches for treating these
individuals do not result in meaningfully improved mobility over time. Physical Therapy (PT) is essential for
treating CP but the amount of PT is generally insufficient, and the delivery of PT can be inefficient. There is
currently no viable way to provide a sufficient dose of PT that will lead to long-term improvements in mobility and
reduce the negative physical and social outcomes noted above. BiOMOTUM’s (applicant) goal is to create a
reimbursable wearable system for children with CP that will (1) make walking easier and improve free-living
mobility, (2) increase the dose and precision of ankle plantar-flexor therapy to produce lasting improvements in
neuromuscular function, and (3) create a virtual community to incentivize the use of the system and track
improvement. To achieve these goals, this project uses a lightweight, low-profile, battery-powered, wearable
Robotic Ankle Assistive Device (RAAD). The overall objectives of this proposal are to establish feasibility of the
RAAD system to improve mobility in free-living settings and to establish the RAAD as an effective tool to provide
increased dose and precision of targeted ankle therapy. The first specific aim is to complete a personal-use
feasibility analysis of ankle mobility assistance. It is hypothesized the children will be able to safely walk faster
and travel farther in the community when using the RAAD device vs. without the device. The second specific
aim is to gather feedback to design and prototype a minimum viable product for use in clinical and community
settings. The third specific aim is to quantify the potential for the RAAD system to increase the effectiveness of
clinical gait therapy. Individuals with CP will complete three training sessions: RAAD assistance, RAAD
resistance and standard of care. Muscle activity and step activity will be measured during each session. It is
hypothesized that the RAAD assistance and resistance therapy will improve ankle plantar-flexor muscle activity
and treatment session quality compared to traditional physical therapist-guided gait training. The fourth specific
aim is to assess the benefits of repeated gait training with RAAD assistance and resistance. Individuals with CP
will participate in a 4-week assistance or resistance intervention and mobility outcomes will be quantified pre and
post intervention. It is hypothesized that both assistance and resistance training will improve mobility outcomes.
This proposal paves the way for commercializing the device and implementing future longitudinal interventions
that will investigate the potential for RAAD to improve quality of life and long-term clinical outcomes.

Public health relevance
PROJECT NARRATIVE Many children with physical disabilities have difficulty walking, which contributes to drastically reduced levels of physical activity and lower quality of life. This proposal will establish the feasibility and efficacy of a lightweight, battery-powered, wearable robotic ankle assistive device to improve the mobility of children with gait disorders in both clinical and free-living settings. In the long-term, this research will improve our ability to optimize the prescription of wearable assistive devices aimed at improving mobility and increasing habitual physical activity in individuals with movement disorders.